Supplement to Effectiveness of the On the Move group exercise program to improve mobility in community-dwelling older adults

Effectiveness of the On the Move group exercise program to improve mobility in community-dwelling older adults
Gardenia Juarez, a first-generation Hispanic/Latina woman, is a promising rehabilitation science graduate student who is
interested in pursuing a career in aging and implementation science research. Supplemental activities will focus on Ms.
Juarez’s research and career development. These activities will occur under the mentorship of Jennifer Brach, PhD, PT,
FAPTA, a successful aging and rehabilitation science research mentor and Principal Investigator of the parent study. The
research and career development aims are strongly linked with the activities in the parent grant and supported by the
infrastructure and resources of Dr. Brach’s research laboratory and her ongoing work with the On the Move (OTM)
evidence-based exercise program. The aims of Ms. Juarez’s supplemental research project are to 1) identify
organizational contextual determinants (barriers and facilitators) to the adoption of OTM and 2) examine the
associations of organizational contextual determinants to the acceptability, appropriateness, and feasibility of
implementing OTM. Ms. Juarez will obtain robust experience by being a part of a multi-disciplinary research team
conducting a large cluster-randomized trial. She will interact with all study investigators (Drs. Beach, Freburger and
Weiner) and participate in all research team meetings. Specifically, she will participate in the identification of measures
of organizational contextual determinants, recruit and enroll organizations into the study, assist in the interviews and
focus groups (including non-adopter organizations), participate in the coding and analyses of qualitative data, and
interpretation of the findings. This project will serve as Ms. Juarez’s doctoral dissertation with Dr. Brach as the chair of
her doctoral committee. She will work with Dr. Brach and her dissertation committee to disseminate her findings at an
appropriate scientific meeting and through peer-reviewed publications. Ms. Juarez’s career development plan allows her
to acquire advanced knowledge in the areas of aging, health promotion, and implementation science and the necessary
skills for a career conducting community-based research. Career development goals to be accomplished through Ms.
Juarez’s graduate training and supported by this supplement include: 1) develop knowledge of aging and health
promotion; 2) develop knowledge of implementation science principles; 3) acquire skills in designing and conducting
clinical trials; 4) acquire skills in qualitative methodologies; and 5) develop leadership and professional skills important
for academia. We anticipate that at the end of this career development plan, Ms. Juarez will have the necessary
knowledge and skills to pursue the next phase of scientific training, a post-doctoral fellowship in implementation science
or a career as a junior faculty member.

Public health relevance
Public Health Relevance Statement Supplemental activities will focus on research and career development activities of a promising Hispanic/Latina, first-generation woman and graduate student who is interested in a career in implementation science. Proposed research complements the parent study and supports development of a future investigator in aging and implementation science.